MATHEMATICAL AND COMPUTATIONAL METHODS FOR SOLVING NONLINEAR EQUATIONS

Purpose This project helps investigators to cope with complex equations that model biological systems. PROJECT 1:David Ruskin and Judy Walters, NINDS.In order to monitor variations in neuron firing rates in a live animal, this group wanted a MATLAB version of the Lomb periodogram, as published by Press et al. "Numerical Recipes in C", Cambridge Univ. Press, Cambridge 1988. The authors describe this program as "turgid code", and indeed, it took quitean effort to get it right. I wrote two MATLAB versions, one based on the above book, and a simpler but less efficient version based on a paper by Jeffrey Scargle: Astrophys. J. 263 (1982),835-853. The object was to allow complete control over the test cases to insure bug-free code. In the process, I found that the method is flawed, and can give misleading information about the presence and power of a given frequency. I wrote a paper about how to correct the problem, and submitted it to the journal "Astrophysics and Space Science", who published the original Lomb paper, and has now accepted mine, subject to minor revisions. PROJECT 2: Richard Hendler, NHLBI. Bacteriorhodopsin (bR)is an important biological energy transducer. It converts light into electrochemical potential by pumping protons across the cell membrane. bR is one of those molecules, like hemoglobin and cytochrome oxidase, in which a lot is known about the structure, but important aspects of the mechanism are still unclear. We are using mathematical modeling to decide the merits of several models that have appeared in the literature in recent years, including our own. The experiment consists of exposing bR to a laser flash, and measuring absorbance spectra as a function of time. We have developed new techniques that will enable investigators to extract more information from their data than was previously thought possible. For example, the fraction of bR reacting to the flash and the fraction in each of the fast and slow subcycles are now resolvable, along with absolute spectra rather than difference spectra. We have spent much of the year refining our methods and writing two papers, the first about the methods themselves, and the second about results specific to bR. These two papers have now been submitted. PROJECT 3: Peter Basser NICHD In the past, we have shown that at least seven MRI images are required to get complete information about the orientation of diffusion, e.g. in nerve fibers. However, when the situation is complicated by more than one kind of sample in a voxel, and especially by more than one orientation (e.g. when nerve fibeers cross), seven images no longer suffice. We are designing imaging strategies to resolve these more complex cases. PROJECT 4: P-SCAN The popular program P-SCAN for DNA microarray analysis is written mostly in MATLAB. This year, I have been an occasional consultant in upgrading the performance of several P-SCAN functions. PROJECT 5: MATLAB MATLAB is a major numerical software package in use by hundreds of investigators at the NIH. The 2-day MATLAB course had been given in spring and fall for the past ten years, undergoing revision as the language expanded in scope. The class notes, originally a small pamphlet, have grown to 147 pages requiring continual revision as the language evolves. The current version, MATLAB 5, is a major expansion of the language, and has proved too large for the 2-day format. For the first time this year, the course was expanded to 3 days, and the response has been most favorable.